National Institute of Diabetes and Digestive and Kidney Diseases ATLAS (D2K-ATLAS) Center as an accessible, comprehensive data portfolio for renal and genitourinary development and disease

PROJECT SUMMARY
Technical advancements have enabled the generation of large amounts of highly specialized and complex
molecular data (e.g., single-cell transcriptomics and multiplex imaging) to study organ development, healthy and
disease states, and differences between biological sexes at unprecedented scale and cellular resolution. This
complexity introduces challenges in the organization and curation of these datasets and in applying
computational methods. There is a need to provide accessible advanced analysis and visualization tools, and to
utilize our domain knowledge to enable entry points for the research community to reuse data and ask new
questions about human health and generate new hypotheses. Our overall objective is to create connections
between molecular data of kidney and lower urinary tract present in GUDMAP, RBK, KPMP, HuBMAP (each
consortium is represented on our team), so researchers with varying levels of experience can find relevant data,
understand connections across model systems, and gain new insight by using provided analysis tools. Our vision
is to establish the National Institute of Diabetes and Digestive and Kidney Diseases ATLAS (D2K-ATLAS) as a
comprehensive data portfolio for renal and genitourinary development and disease. Curated data-driven
reference data enables comparative analysis using advanced computational studies across various parameters,
including sex, age, species, and healthy and disease settings. Providing analysis and visualization tools will aid
knowledge transfer and broaden the usability of submitted data. Aim 1) Create a comprehensive, integrated, and
F.A.I.R. cloud-based data management system integrating GUDMAP and RBK data, multi-species ontologies to
facilitate cross-linkage of multi-study, multi-modality, and multi-consortia data, and web applications for data
exploration and access. Aim 2) Implement web-based tools, data integration, human and mouse reference atlas,
and data visualizations that enable researchers to interact with quality controlled, curated data for advanced
analysis by developing processes, tools, and an access control policy for data collection, curation, publication,
image annotation, quality control, analysis, and visualization. Aim 3) Administration, coordination, collaboration,
dissemination, and outreach by our D2K-ATLAS Center, which will facilitate, communicate, and collaborate with
the NIDDK, the GUDMAP/RBK Steering Committees and Consortium Management Boards, and investigators to
achieve consortia goals, including education, outreach, and management of the Opportunity Pool awards. This
effort will be significant because it provides curated reference datasets, establishes aligned data stewardship
standards across the represented consortia and creates a consensus anatomical/cell type ontology linked to key
biomarkers. Computational analysis is both an advancement and a barrier, requiring bioinformatics expertise.
Our innovative proposal lowers these analysis barriers by providing layers of analysis and visualization tools for
users of varied computational expertise and creates robust, data-driven reference standards for the research
communities of mouse and human renal and genitourinary development and disease.

Public health relevance
PROJECT NARRATIVE The proposed D2K-ATLAS is set to promote the availability and encourage the reuse of high-quality big data generated by NIDDK initiatives to understand fundamental healthy and disease processes of the genitourinary system to benefit public health. By establishing harmonized curation and quality control standards shared among several NIH-funded consortiums, researchers of varying experience can efficiently identify and utilize provided analysis and visualization tools on available data. This effort is relevant to NIH’s mission because it increases access to advanced analysis tools, furthers engagement with trainees in the life sciences, and promotes the reuse of expensive existing data to generate new hypotheses.